Leukotriene B4 and IL-8 in alpha-1 heterozygotes (PI*MZ genotype)

Project Summary/Abstract: The purpose of this K23 Career Development Award is to develop Vickram
Tejwani, MD as an independent investigator with a focus of translational investigation in heterogeneity of
disease among alpha-1 heterozygotes. Dr. Tejwani has shown great promise as a young investigator and this
proposal builds on his early experience with additional training in genomic and primary prospective recruitment
of study participants, as well transcriptional analysis. This grant will allow hands-on experience enrolling
participants, obtaining biospecimens and wet lab processing, as well as genomic and transcriptional analysis of
existing datasets. This experience will be supplemented with structured coursework focused on genomic and
transcriptional analytic techniques and in aggregate, will accelerate development of an independent career
path. Dr. Tejwani will benefit from a multidisciplinary team of mentors, including Dr. James K. Stoller, a world
authority on alpha-1 antitrypsin deficiency, Drs. Joe Zein and Victor Ortega, experts in genomic analyses and
particularly the SERPINA1 gene which encodes for the alpha-1 antitrypsin protein, and Dr. Mitchell A. Olman,
who will provide wet lab mentorship and resources. In aggregate, this mentorship team and institutional
commitment to his research career will provide Dr. Tejwani the multidisciplinary training and guidance to
develop into an independent investigator.
Chronic obstructive pulmonary disease (COPD) is a highly variable disease with limited therapies, in
part given prior studies do not account for disease heterogeneity with differential therapeutic responses. A
deficiency of alpha-1 antitrypsin (AAT), the protein encoded for by the SERPINA1 gene, remains the best
described COPD endotype. However, the heterozygous state with one wild-type allele (M) and one Z variant
allele (rs28929474), known as PI*MZ, is an understudied and highly prevalent potential phenotype (affecting
more than 35,000,000 globally). Epidemiologic studies demonstrate PI*MZ individuals have a wide array of
disease burden among PI*MZ individuals and there is very little understanding of biologic correlates that might
uniquely contribute to or be associated with disease development. Dr. Tejwani’s proposal addresses this gap
through a multiomics approach with single center recruitment strengthened by analysis of existing
biospecimens and genomic data from multicenter studies. He proposes to assess airway leukotriene B4 and
interleukin-8 and its association with baseline disease severity, as well as longitudinal outcomes. He will also
conduct for the first time, a gene-gene interaction, to see if variants in genes encoding for leukotriene B4- and
interleukin-8-related genes are associated with COPD in those alpha-1 heterozygotes. Results from this study
will generate preliminary data to compete for an R01-level award to conduct a trial of leukotriene- or IL-8-
modifying agents on respiratory health among PI*MZ individuals utilizing leukotriene B4 and interleukin-8
airway inflammation or genotypic variants as inclusion criteria or effect modifiers.

Public health relevance
Project Narrative Chronic obstructive pulmonary disease (COPD) is the third leading cause of death worldwide and a highly variable disease with limited therapies, in part given prior studies do not account for disease heterogeneity with differential therapeutic responses. An understudied and highly prevalent potential phenotype is the heterozygous state of the SERPINA1 gene (encodes for alpha-1 antitrypsin protein) with one wild-type allele (M) and one Z variant allele (rs28929474), known as PI*MZ. We propose studying airway inflammatory and genotypic contributions to disease development among PI*MZ individuals to identify biologic correlates of disease severity and potential treatment targets for a highly prevalent disease phenotype.